COBRE Center for the Promotion of Cancer Health Research (CePCHe)

COBRE Center for the Promotion of Cancer Health Research (CePCHe)
The University of Puerto Rico (UPR) and the University of Puerto Rico Comprehensive Cancer Center (UPRCCC), propose a new Center of Biomedical Research Excellence (COBRE) focused in providing valuable science-based information to enhance prevention and cancer care for all Americans. The proposed Center for the Promotion of Cancer Health Research (CePCHe) will (1) address high-impact, interdisciplinary scientific questions through methodologically rigorous and thematically diverse cancer research; (2) build sustainable research capacity to respond to emerging challenges in cancer etiology, prevention, and treatment; (3) expand the pipeline of early-stage investigators, postdoctoral fellows, and graduate students through structured mentorship and research support, enhancing their competitiveness in the biomedical workforce; and (4) establish a translational framework for disseminating research findings to inform scientific methodologies, evidence-based decision-making and public health policy at a national level.

Public health relevance
The Center for the Promotion of Cancer Health Research (CePCHe) will be driven by rigorous scientific methodology to advance cancer prevention and care across the United States. CePCHe will implement an integrated research strategy—encompassing basic, translational, and clinical sciences—to produce high-impact, reproducible findings that address pressing challenges and existing paradigm in cancer research. By enhancing the research infrastructure at the University of Puerto Rico (UPR), the Center will build national scientific capacity and train a new generation of early-stage investigators equipped with the expertise to lead innovative, methodologically sound cancer studies with broad nationwide applicability.